Determining the Molecular Origins of Allostery for the RNA Polymerase from the He

DESCRIPTION (provided by applicant): Determining the Molecular Origins of Allostery for the RNA polymerase from the Hepatitis C Virus Abstract Hepatitis C virus (HCV) infects 170 million people worldwide, and approximately 3-4 million people within the United States. To date, there is no cure for this disease, and 25% of individuals living with HCV contract chronic liver ailments such as cirrhosis or liver cancer. The HCV RNA polymerase (gene product NS5B) has become a drug target because of its importance in viral replication. Several small molecules have been identified that inhibit NS5B and bind outside of the active site; these are referred to as allosterc inhibitors. There are five different allosteric binding sites that have been identified, and severa crystal structures of NS5B enzyme bound to various inhibitors exist. However, a mechanism of inhibition is unclear from the structural data alone and has yet to be conclusively determined. We hypothesize that one can understand the effect of allosteric inhibitors on the functional properties of NS5B by using molecular dynamics simulations to study the enzyme in a free state and bound to various inhibitors. Molecular dynamics is an optimal tool to study this problem because it can provide information about both structure and dynamics at a level of fine detail. By understanding the structural, dynamic, and thermodynamic changes that accompany ligand binding, we hope to determine the molecular origins of allosteric inhibition in NS5B. In the process we will gain essential information on how NS5B and other viral polymerases replicate RNA. Besides illuminating fundamental questions regarding the link between enzyme function and dynamics, this information may aid in the development of novel and more effective inhibitors for NS5B, and ultimately better treatments for HCV.

Public health relevance
PUBLIC HEALTH RELEVANCE: The proposed research will provide a better understanding of allosteric inhibition in the RNA polymerase from Hepatitis C virus. In the short term, this project will reveal a mechanism of inhibition for the polymerase and suggest novel modes of inhibition. In the long term, the knowledge from this project can be used to identify better ways to inhibit this enzyme and thus improved treatments for patients suffering from Hepatitis C virus infection. __SpecificAimsTextDelimiter__ Specific Aims Hepatitis C Virus (HCV) affects 180 million people world-wide and 3-4 million people in the United States. There is no cure for HCV and the only approved treatment has 50% effectiveness and severe side-effects. Thus, novel treatments for HCV are sorely needed. The RNA polymerase from HCV (gene product NS5B) has become a drug target because of its essential role in viral replication. X-ray crystallographic structures have revealed that NS5B exhibits at least two conformations: open and closed, and has five allosteric binding sites (binding sites outside of the active site) where many small molecules have been shown to bind and inhibit polymerase activity. Despite the abundance of structural and biochemical data, the mechanism by which NS5B replicates RNA or how inhibitors prevent this process is unknown. Ultimately, our long-term goal is to create novel treatments for HCV. The overall objective of this application, which is the next step toward attainment of our long-term goal, is to understand the intrinsic structure, dynamic, and thermodynamic properties of NS5B and how they are altered upon inhibitor binding. Our central hypothesis is that inhibitor binding disrupts the dynamics (i.e. correlated motions and sampled conformations) necessary for polymerase function. Thus far the available structural data has not provided a molecular level understanding of allosteric inhibition, suggesting that a description of enzyme dynamics is necessary to understand the effect of allosteric inhibitors on NS5B. The rationale that underlies the proposed research is that once we understand the intrinsic dynamics of NS5B and how allosteric inhibitors disrupt those motions, we can propose novel modes of inhibition, thereby creating new treatments for HCV. We plan to test our central hypothesis and, thereby, attain the objective of this proposal by pursuing the following specific aims: 1. Determine the intrinsic structural, thermodynamic, and dynamic properties of NS5B and how inhibitor binding affects these properties. Our working hypothesis is that inhibitor binding disrupts correlated motions and changes the conformations sampled compared to a ligand-free enzyme. 2. Identify amino acids outside of the active site that modulate enzyme activity. This will test our understanding of how allosteric effects in NS5B work. Our working hypothesis is that conserved residues that participate in low frequency motions play a large role in mediating the enzyme's intrinsic function. This will be determined in two ways: " A: Predict point mutations in NS5B that will i) disrupt functionally important enzyme motions in the absence of inhibitor or ii) maintain functionally important enzyme motions despite the presence of an inhibitor. " B: Determine the effect of these mutations on NS5B dynamics (molecular modeling) and RNA polymerase activity (molecular biology). It is anticipated that these aims will yield the following expected outcomes. First, we will be able to link specific correlated motions and enzyme conformations to polymerase function. Second, we will determine a mechanistic basis for allosteric inhibition in NS5B. Collectively, these outcomes will have an important positive impact because they will enable us to identify novel ways of inhibiting the enzyme, thus providing a path towards novel treatments for HCV.